INVESTIGATION OF CP-101,606 IN MULTISYSTEM ATROPHY

This study will examine the effects of CP-101,606 on the symptoms of patients with multisystem atrophy, and assess the safety and tolerability of CP-101,606. This protocol has now been terminated.